ANALYSIS OF AN ONCOGENE RELATED TO A GROWTH FACTOR AND ITS RECEPTOR

We have analyzed the abnormalities of growth factor and its receptor genes in human tumor samples by Southern hybridization. No remarkable gene amplification or rearrangement of platelet- derived growth factor (PDGF)-A chain, c-fms, c-ros or fyn was detected in 124 (22), 99 (21) and 72 (20) tumor cells (tissue species), respectively. Recently, we have isolated five genomic DNA clones homologous to the proto-oncogene family, which includes fms, kit and PDGF receptor.